THE IDENTIFICATION AND VALIDATION OF EPITOPES CONSERVED IN VIRAL PATHOGEN FAMILIES WITH PANDEMIC POTENTIAL

This contract will identify and validate epitopes conserved in viral pathogen families with pandemic potential in accordance with NIAID’s Pandemic
Preparedness Plan. Accordingly, for each viral family we select a prototype virus that will be utilized in the epitope identification screen. The viral families and prototype viruses included are: Coronaviridae (SARSCoV-
2), Flaviviridae (DENV2), Togaviridae (CHIKV)), Paramyxoviridae (Measles), Arenaviridae (Lassa), and Picornaviridae (Poliovirus).